Identifying and addressing missingness and bias to enhance discovery from multimodal health data

PROJECT SUMMARY
Recent successes of machine learning (especially deep learning) in analyzing electronic health record (EHR) data have
not only stimulated excitement in stake holders but have also raised concerns potential unfair or biased clinical decision
making facilitated by machine learning. A number of fairness measurements have been proposed. However, they
underappreciate the chronical systematic differences between the distributions of protected and unprotected groups. Hence,
when used to develop machine learning methods, they may worsen within-group issues and dampen performance of the
trained machine learning models. The situation can be further complicated by missing values that are common in EHR data,
which will exacerbate unfairness if not handled properly. In this project, we aim to develop a novel fairness evaluation
methodology (Aim 1) and incorporate it into the development of innovative machine learning models and techniques to
reduce biases and increase interpretability (Aim 2). To better and more fairly handle missing values, we will develop new
machine learning models that contain trainable in-process missing value imputation components and new algorithms to train
them with constraints defined by our new fairness evaluation method (Aim 3). In addition, we will develop proactive
machine learning techniques to advance heath equity (Aim 4). We will evaluate and improve our new fairness measurements
and machine learning techniques in the context of facilitating clinical decision making (Aim 5). Large datasets from two of
the largest US healthcare systems will be used in carrying out the proposed research.

Public health relevance
Narrative Increases in computational power and data availability have facilitated development of advanced statistical methods and artificial intelligence (AI) technologies, powerful tools for knowledge discovery and facilitating clinical decision making, but have also made evident the existence of biases and blind spots, both implicit and explicit, in both data and models. As such, fairness, interpretability, and reproducibility are among several emerging areas in need of research both in computer science and biomedical informatics. This project will focus on developing a novel fairness metric and new machine learning techniques for real-time clinical decision support in the critical care and ICU settings to address issues of health diversity, equity, and inclusion through the use of fair machine learning algorithms to appropriately handle missingness and bias in clinical data.